Research Education Component

ABSTRACT: RESEARCH AND EDUCATION CORE
The overarching goal of the Research and Education Core (REC) of the Michigan Center on Contextual
Factors in Alzheimer’s Disease (MCCFAD) is to diversify and educate the professional research workforce
addressing the brain and cognitive health of older adults. REC is central to MCCFAD because it directly
educates, mentors, and supports junior and mid-career investigators from underrepresented groups. Enhanced
diversity in the professional research workforce who study the brain and cognitive health of older adults is
critical to advancing knowledge about and improving the care of older adults in the U.S. REC synergy with the
Leadership and Administrative, Analytic, and Community Liaison and Recruitment Cores will be instrumental in
achieving these aims, as will collaborations with rich resources available at the University of Michigan (UM),
including NIA Centers, Inter-Consortium for Political and Social Research, the Health and Retirement Study
(HRS), and partner institutions (Michigan State University, Wayne State University, Oakland University, UM-
Dearborn). REC specific aims are to: (1) Support pilot studies for MCCFAD Research Scientists (RS) in ADRD
epidemiology, health economics, and culturally-sensitive care; (2) Provide sustainable mentoring activity for
MCCFAD RS to achieve independent investigator status; (3) Offer professional development and education in
ADRD disparities; and (4): Evaluate REC activities. Expert mentorship in health disparities and minority aging
research will primarily be provided to RS through an individualized, integrative and often trans-institutional
mentoring team, a monthly seminar series, professional development sessions, and a yearly Summer Data
Immersion (SDI) program to catalyze new and enduring research collaborations. Moreover, RS mentoring
activities will continue beyond their funded year. We have designed a unique and exceptional educational
experience that will increase the workforce interested in and knowledgeable about contextual factors related to
ADRD. A team of expert faculty will guide these activities, which exemplify the overarching REC core value of
team science. The impact of the REC is expected to be broad because we have designed activities to target
and benefit not only funded RS (e.g., integrative mentoring team; monthly seminar series), but also national
researchers (e.g., SDI) and the larger scientific community as a whole (e.g., peer-reviewed publications and
presentations at professional meetings generated through RS pilot projects and SDI activities, workshops on
the responsible conduct of research with Middle Eastern and North African (MENA) and Latino populations).